Expansion of Mail-Delivered Harm Reduction Services in the U.S.

PROJECT SUMMARY
COVID-19 has led to record high overdose deaths in the US and high risk for future injection-related HIV and
hepatitis c (HCV) outbreaks. Innovative approaches are urgently needed to expand access to syringes and
naloxone, a drug used for opioid overdose reversal, for the prevention of HIV/HCV outbreaks and opioid
overdose fatalities. Expansion and scale-up of mail-based harm reduction services may address harm
reduction access gaps by providing a more convenient and confidential way to obtain services. To inform
scale-up these services, we aim to 1) describe policy barriers to national expansion of mail-based syringe
services and fentanyl strip distribution, 2) conduct a national, longitudinal cohort study to examine predictors of
uptake and long-term engagement in mail-based harm reduction services, and 3) assess the add-on harm
reduction and health services preferences of mail delivery clients. For Aim 1, we will conduct a systematic legal
review of relevant laws in each of the 50 states and the District of Columbia to determine whether and how
state law may impact the legality of distributing syringes and fentanyl test strips by mail. We will develop a
taxonomy of policies that may prevent legal expansion of mail-delivered syringes. To understand the
perception of legal risks associated with mailing syringes among potential adopters, we will survey and
interview 20 stakeholders (i.e., health departments and SSPs) from states representing different legal
environments for mail-delivery. For Aim 2, we will build on a social media-recruited survey examining uptake
and acceptability of mail-delivered harm reduction by expanding the follow up period of that survey from 6
months to 12 and 18 months and expanding the sample size of this survey. This will allow us to assess
predictors of uptake and mail-delivered harm reduction engagement over the long-term in order to fully
understand who uses mail-delivered services and how these services are being used over time. For Aim 3 we
will design and implement discrete choice experiment (DCE) surveys to determine mail-based service client
preferences for receiving add-on harm reduction and health services. These results will be disseminated to
policy stakeholders, potential adopters, and NEXT affiliates to inform expansion and scale-up of mail-based
harm reduction services, improve engagement with current NEXT users, and expand the type of services
offered through these programs.

Public health relevance
PROJECT NARRATIVE Innovative approaches are urgently needed to expand access to syringes and naloxone (a drug used for opioid overdose reversal) for the prevention of HIV/HCV outbreaks and opioid overdose fatalities. Expansion and scale-up of mail-based harm reduction services may address harm reduction access gaps by providing a more convenient and confidential way to obtain services. To inform scale-up these services, we aim to 1) describe policy barriers to national expansion of mail-based syringe distribution, 2) conduct a national, longitudinal cohort study to examine predictors of uptake and long-term engagement in mail-based harm reduction services, and 3) assess the add-on harm reduction and health service delivery preferences of mail delivery clients.